Optimized Anti-Epileptic Screening Using Drosophila Models

Millions of people suffer from epilepsy in the US alone. In addition, many of these individuals do not respond well
to current anti-seizure medications (pharmacoresistant epilepsy). Screening for new anti-seizure medications
has proven difficult, especially using in vivo models of human epilepsy. We recently developed a model of
pharmacoresistant epilepsy in the genetic model organism Drosophila melanogaster (fruit flies). Using this new
in vivo model we screened a large chemical library of 1280 previously approved drugs and found 8 that could be
repurposed, off label, for the treatment of pharmacoresistant epilepsy. Here we will improve the anti-seizure
screening process in Drosophila using multi-fly video tracking tool (IowaFLI Tracker) and tethered fly
electrophysiology to increase the screening efficiency of the system (R61 phase). Then we will use these new
tools to screen a large collection of >3500 previously approved drugs from the Yale Center for Molecular
Discovery for repurposing in humans (R33 phase). This project will not only revel new drugs that can be
repurposed for the treatment of Duplication 15q pharmacoresistant epilepsy but will also provide powerful new
tools for in vivo screening of anti-seizure drugs using other fly models of human epilepsy that already exist or
could be easily constructed using syntenic mutation techniques.

Public health relevance
Repurposing previously approved drugs for the treatment of epilepsy is a powerful approach to drug discovery that does not require the usual regulatory process of drug approvals. Here we will refine a new epilepsy model in fruit flies to screen more than 3500 previously approved drugs for potential treatment of seizures in humans. These repurposed drugs could then be used, off-label, for the treatment of seizures in people where current anti- seizure medications are not effective.